Core E: Outreach, Recruitment, and Engagement Core

PROJECT SUMMARY/ABSTRACT - OUTREACH, RECRUITMENT AND ENGAGEMENT CORE The Outreach, Recruitment and Engagement (ORE) Core plays a critical role in the ADRC, interacting with all other Cores, and developing and coordinating its outreach, recruitment, and engagement efforts across our geographically diverse state.1 Arizona's population of 7.27 million people2 that are aged 65 and older and living with Alzheimer's disease (AD) is expected to grow 33.3% by 2025—the largest increase in the US.3 Hispanics/Latinos constitute Arizona's largest ethnic minority (31.7%), and Native Americans alone (5.3%) represent the state's largest racial minority.2 The ORE Core reaches out to underserved communities for education, engagement, and research and to help ensure diverse participant cohorts in the Clinical Core, the Neuropathology Core (via brain and body donation), multicenter programs initiated by NIA, and related research. The ORE Core recognizes that ADRD not only affects people living with ADRD, but also Arizona's 346,000 ADRD family caregivers.3 It serves as a unique resource by disseminating up-to-date information on ADRD, research studies for interested healthy adults, and advancements in ADRD research, treatment, and care for patients and caregivers. Arizona's diversity and our multi-organizational model require that our ORE Core approach be intentionally multifaceted to meet the needs and nuances of our ADRC's organizations, community partners, and diverse communities. We use social marketing and community participatory research methods to help identify best practices, build on past successes and lessons learned, and leverage new opportunities. Examples include: (1) leading or collaborating on events about advances in ADRD research, treatment, and care, including events for underserved communities (e.g., Banner Alzheimer's Institute's Annual Native Americans & Alzheimer's Disease Conference); (2) expanding Zoom delivery of events and award- winning caregiver programs in English and Spanish;15-18 (3) developing new or updating existing products (e.g., Latino Personal Stories videos); (4) fostering minority recruitment through registries and other studies like MindCrowd,21,22 Alzheimer's Prevention Registry,19 and NIH's All of Us; (5) partnering with the Native AD Resource Center for Minority Aging Research (NAD RCMAR) at Washington State University and the Minority Aging Health Economics Research Center at University of Southern California; (6) advancing our social media presence through an updated website and via Facebook, Twitter, and YouTube; and (7) gathering feedback on community needs and ORE Core strategies from our Community Advisory Board, stakeholder focus groups, and recruitment and retention tracking forms. ORE activities will incorporate our ADRC's theme of “blood- based biomarkers (BBB) in the diagnosis, preclinical study and prevention of ADRD.”